Hippo-YAP signaling in cardiac regenerative repair

Project Summary
This R01 application will investigate a novel signaling pathway, the Hippo-YAP pathway, in mammalian heart
injury. The long-term goal is to develop new treatments for patients with heart failure by generating treatments
that promote a productive response to injury. The objectives of this application are to gain insights into gene
therapy strategies that knock down Hippo signaling in cardiac tissue following myocardial infarction. The
central hypothesis is that our Hippo knockdown gene therapy approaches can be modulated to improve
cardiac function safely and efficiently in mice models of ischemic heart failure. The specific aims are to
investigate the YAP-mediated mechanisms for induction of regenerative repair and to create a multi-omic map
of the post-myocardial infarction heart. Further preclinical refinement of our gene therapy knockdown strategy
is a required and important step to bring the approach to the clinic. The project is conceptually and technically
innovative. Concepts to be tested include new ideas in cardiac biology and cutting-edge single-cell genomics
technologies to address hypotheses. The significance is high because there are no treatments for heart
failure, and devising ways to improve patient outcomes is highly significant.

Public health relevance
Project Narrative Heart failure due to cardiomyocyte loss, progressive fibrosis, and pump dysfunction after ischemic heart disease is the leading cause of death in the United States. Poor adult cardiomyocyte regenerative potential after acute damage results from inadequate adult cardiomyocyte proliferative capacity and extensive fibrosis. Our goal is to devise new methods to promote heart repair.